Core F: Artificial Intelligence and Bioinformatics

CORE F: ARTIFICIAL INTELLIGENCE AND BIOINFORMATICS – SUMMARY/ABSTRACT
This Core will meet two major unmet needs for our Nathan Shock Center and the geroscience community at
large. First, we will offer integrated statistical and bioinformatics consulting for all Center-supported projects
from experimental design through to publication. This ensures that our Center resources have the greatest
opportunity to support high-impact studies in aging research and also meets an important goal of enhancing
rigor and reproducibility in biomedical research. Second, we will bring state-of-the-art computational
approaches, particularly in the area of Artificial Intelligence (AI), to support Center users and maximize the
impact of the other Resource Cores.